SQUEEGEE DESIGN EFFECT ON CARPAL TUNNEL PRESSURE

DESCRIPTION: (Adapted from the Investigator's Abstract). Repetitive use of hand tools, in particular those that compress the palm of the hand and are held with a pinch or precision grip may be a large part of the high incidence of carpal tunnel syndrome (CTS) that is overwhelming the industrial work place. This proposal is to conduct preliminary investigations into the relationship of carpal tunnel pressure (CTP) to the design of handles used on squeegees and related hand tools such as pliers and screwdrivers. The purpose of this investigation will be to determine the feasibility of preventing CTS using the squeegee handle as a hand tool model and redesigning the standard shape. In Phase I we will investigate how handle shape and size affects CTP to determine the feasibility of designing an ergonomically sound squeegee handle. If the results of this investigation suggest an ergonomically sound squeegee handle design will prevent CTS then in Phase II we will use the results of our study to design and test prototype squeegee handles and develop the biomechanics to properly use these ergonomic handles. The screen printing industry is actively seeking a solution to the rampant CTS problem.